Emotion Processing: Risk for Psychopathology in Children

These experiments will further understanding about how and why child adversity leads to a broad range of
mental and physical health problems. Although millions of children experience various forms of child adversity
each year in the US, little is understood about how this experience influences brain-behavioral development.
The General Aim of this research is to determine how environmental experience shapes neural circuitry in
ways that lead to child mental health problems, and determine how these systems can be targeted to provide
treatments for affected individuals. Here, we will test aspects of learning that might underlie problems in
adversity-exposed children by focusing on the way unstable environments influence decision-making. Once we
identify a mechanism, we will advance our basic science to a pre-clinical space by determining if these
mechanisms are responsive to laboratory manipulations. The Specific Aims are to specify the mechanisms
affected by child adversity that lead to developmental changes in systems needed to effectively learn to
communicate, interpret, and regulate emotion in the context of social interactions. We will focus on how
children learn from these experiences to determine which of these processes are most amenable to change.
The proposed experiments combine neuroimaging, behavioral, and computational approaches to examine
precise and novel questions about how experiences of child adversity are transformed into disruptions of the
brain networks underlying emotional pathologies. This project: (1) Examines developmental change in children
ages 9-11 years, covering critical transitions when many mental health problems emerge, (2) Probes discrete
developmental mechanisms that can be targeted for intervention, (3) Is amply powered to properly test the
hypotheses, (4) Characterizes aspects of relevant brain-behavior relationships are related to both RDoC
dimensional constructs and DSM diagnoses, and (5) Employs sophisticated computational rigor to truly
interrogate the critical questions under examination. Because child adversity is a powerful determinant of many
subsequent mental health problems, the data generated from this project has profound implications for
conceptualizing novel and more precise treatments for vulnerable children. It will do so by determining effects
of chronic adversity exposure on human neural circuitry early in development, when the brain may be
particularly sensitive to environmental influences. The project moves away from description of risk groups to
defining and specifying mechanistic ways in which the environment creates long-term effects on brain and
behavior. These foci hold tremendous promise for advancement of knowledge and application to improvement
of public health.

Public health relevance
PROJECT NARRATIVE The research proposed in this application seeks to understand how the experience of childhood adversity exerts a lasting impact on children’s behavioral development. Millions of children experience various forms of extreme adversity each year in the United States and it is known that these individuals are at heightened risk for a broad range of mental and physical health problems. But little is understood about how early experiences of psychosocial stress influence the neural systems that can lead to children’s emotional and behavioral problems.